Quantity Meets Quality: Examining input statistics for early word learning from the infant’s point of view

Quantity Meets Quality: Examining input statistics for early word learning from the
infant's point of view
Project Summary / Abstract
Children acquire language in everyday contexts where the language environment plays a critical
role in supporting early language development. In early word learning, infants learn object names
by linking heard words to seen objects in their environment. This is well recognized as a
computationally complex problem due to referential uncertainty -- at the moment of hearing any
word, there may be many potential referents in the learner's immediate environment. Many
laboratory experiments are designed based on various assumptions about the uncertainty
challenge that young learners face, which may not reflect the uncertainty encountered in everyday
learning experiences. Despite considerable research efforts, little is known about the referential
uncertainty infants face in their everyday contexts. We built a Home-like Observational Multimodal
Environment (HOME) to examine how 12- to 24-month-olds and their parents jointly create input
statistics for early word learning in everyday activities. Using head-mounted eye-tracking
technology in the HOME lab, we will record infant gaze and parent speech during three everyday
activities: toy play, book reading, and meal preparation. We will specifically focus on the moments
when parents produce object names in their speech, precisely measuring the infants' in-the-
moment attention toward those named objects. Through the analyses of high-density gaze and
speech data, we will characterize the referential uncertainty at individual naming instances from
the infant's point of view (Aim 1), examine the computational mechanisms that operate on the
input statistics to achieve successful word learning (Aim 2), compare the quantity and quality of
the input statistics among the three different everyday activities (Aim 3), and determine whether
the quantity and quality of the input statistics in those activities predict individual differences in
vocabulary growth (Aim 4). This proposed work holds significant potential for breaking barriers
that stall the current understanding of early word learning, developing innovative methods to
quantify the multimodal nature of the language environment, and providing mechanistic insights
into the origins and consequences of individual differences in language development.

Public health relevance
Narrative/Relevance The language environment plays a critical role in supporting early language development in young children. The proposed research will develop innovative methods to quantify the multimodal nature of the language environment by measuring infants’ real-time attention to parent speech in everyday activities. A detailed understanding of the input statistics for early word learning will provide mechanistic insights into the origins and consequences of individual differences in language development, and help to identify and address developmental language delays at an early stage, benefiting children who experience such delays.